Career Enhancement Core

CAREER ENHANCEMENT CORE: PROJECT SUMMARY
The UPSTREAM Research Center Career Enhancement Core will facilitate the training and career
development of a diverse cadre of interdisciplinary early-career scholars who are committed to advancing
cancer health equity through research and practice in persistent poverty areas. Leveraging the outstanding
training environment of Stanford, UCSF and UC Davis, we propose to implement the UPSTREAM Scholars
Training Program. The UPSTREAM Scholars Training Program will recruit, select, and train postdoctoral
scholars pursuing independent academic careers in cancer health disparities research. Our proposed career
development program has five pillars: 1) mentored research experience with a mentoring team composed of
Center faculty across institutions and Regional Coalition members; 2) didactic educational program with
curriculum in community engagement; health equity, and the social determinants of cancer; 3) experience
conducting community-led research; 4) career and professional development activities; and 5) vertical and
peer networking within the UPSTREAM Research Center and across the Persistent Poverty Initiative Network.
To complement the in-depth training of postdoctoral scholars proposed under Aim 1 and extend the reach of
the Core, the Career Enhancement Core will offer an intensive short course on the social determinants of
cancer, a new course on leveraging real-world data to reduce cancer disparities in persistent poverty areas,
expert consultations with members of our Regional Coalition, a monthly UPSTREAM Research Center seminar
series, and a cancer health disparities journal club. These activities are designed to be widely accessible to
trainees from diverse career stages within the UPSTREAM Research Center and across the Persistent Poverty
Initiative Network. The Career Enhancement Core will synergize and coordinate with each component of the
UPSTREAM Research Center and further the overall center goal of alleviating cancer health disparities in
communities living in persistent poverty.